Novel animal models of brain longevity and Alzheimer's disease

Summary: Despite enormous resources being committed to study Alzheimer’s disease (AD) there is no effective
treatment or cure. One of the difficulties in developing treatments is the lack of animal models that recapitulate
human sporadic disease. The goal of this project is to apply the power of comparative biology to develop novel
approaches and animal models for AD. We will focus on two rodent species, the naked mole rat (NMR) and
Octodon degus (degu) that represent high resistance to AD (NMR) and susceptibility to sporadic onset AD
(degu). We expect that these novel approaches will uncover new mechanisms of AD and AD resistance and
provide the community with animal models and datasets for future research. In the current funding cycle, we
made significant progress in understanding mechanisms of naked mole rat longevity. We demonstrated that
NMRs are resistant to osteoarthritis and do not undergo thymic involution. We built epigenetic clocks for NMRs
and showed that NMR queens age more slowly. We built a single cell atlas of the NMR hematopoietic system
and identified multiple neotenic traits. We previously discovered that naked mole rats have very high levels of
high molecular weight hyaluronan (HMW-HA) in their tissues. Excitingly, we now show that mice expressing
naked mole rat hyaluronan synthase 2 gene (nmrHAS2) have longer lifespan and healthspan and are protected
from inflammation. Funded by an administrative supplement, we expanded our research into the field of AD. Our
preliminary data suggest that the nmrHAS2 transgene also protects mice from AD. We also established a colony
of degu, a rodent that spontaneously develops AD-like pathology, and discovered that degus are naturally
deficient in methionine sulfoxide reductase (MSR) function, which protects methionines from oxidation. This
result suggests a novel mechanism for sporadic AD: we hypothesize that in sporadic AD low MSR activity
leads to increased methionine oxidation which accelerates the formation of protein aggregates. Project
2 will ask the following questions: What is the mechanism of AD resistance in the NMR? Does elevating HMW-
HA, genetically or pharmacologically, protect from AD and how? What is the mechanism of sporadic AD in degu?
Does MSR deficiency lead to AD in degu, mouse, and human? Our aims are: (1) To uncover novel mechanisms
of AD resistance in the NMR. We will perform transcriptome and proteome comparisons between mouse, NMR,
and a short-lived NMR relative, Damaraland mole rat (DMR). We will further investigate the role of HMW-HA in
protecting from AD and test whether pharmacological agents that increase HA protect from AD. (2) We will
develop degu as a model for AD. We will develop behavioral tests for degu and perform molecular
characterization of degu brains and peripheral tissues. We will examine the role of MSR in AD pathology in degu,
mouse models of MSR deficiency, and in human brains and induced neurons from AD patients. With Projects 1
and 3 we will examine mutation rates and epigenome stability in NMR, degu and mouse brains, and with Project
4 analyze aging and AD clocks.